Genetics of zebrafish germ layer formation

Work focuses on the writing of senior-author manuscripts describing unpublished work on zebrafish embryonic development stemming from Feldman and his colleagues' research from 2004-2012.

9/1/2021 through 8/25/2022 Feldman:

1) maintained mutant zebrafish lines relevant to germ layer formation studies: one-eyed pinhead.
2) Read and assessed the following two articles in the field in his capacity as a member of the Developmental Biology/Pattern Formation Section of Faculty Opinions: (i) "Enhancer decommissioning imposes an epigenetic barrier to sensory hair cell regeneration."
(ii) "tRNA overexpression rescues peripheral neuropathy caused by mutations in tRNA synthetase."